Development of Novel Topical Therapeutics for Psoriasis

Development of Novel Topical Therapeutics for Psoriasis
BioTherapeutics Inc (BTI) is an emerging biotech company that synergistically combines the power of
advanced computational modeling with translational experimentation to accelerate the development of novel
product candidates for precision medicine and health. An unmet clinical need for safer, more effective drugs
for psoriasis remains as current therapies have limited efficacy and adverse side effects.
Psoriasis afflicts over 7 million people in the United States and 15 million worldwide. Current therapies for
psoriasis have limited long-term efficacy but significant adverse side effects. Three-fourths of psoriasis patients
are managed with topical therapies, yet many of these therapies remain corticosteroids, which struggle to offer
sustained remission and have been implicated in decrease responsiveness to treatment in a variety of
autoimmune diseases. Meanwhile, roughly half of patients on oral or systemic psoriasis treatments will
discontinue therapy due to loss of response or concern over side effects. Therefore, there is an unmet clinical
need for the development of more effective, safer, topical therapeutics for the treatment of psoriasis. This SBIR
Phase I application aims to develop a topical, first-in-class therapeutic for the treatment of psoriasis through a
novel mechanism of action at the crosstalk between keratinocytes and immune cells.
The Specific Aims for the SBIR Phase I application are to:
(1) Characterize the therapeutic efficacy of our new therapeutic in a mouse model of psoriasis to determine
the effects on keratinocytes and immune cells through histological, metabolic and flow cytometry analysis.
(2) Develop a topical drug product formulation through generation of five or more prototype formulations and
testing permeation in vitro and therapeutic efficacy in a mouse model of psoriasis.
(3) Evaluate the translational efficacy in human primary cells from psoriasis patients through assessment of
cytokine profile and functional assays.
Expected successful outcomes: i) 50% reduction in composite score on day 7 with at least one dose of treatment
in vivo, ii) >10% permeation by IVPT in our lead topical prototype, and iii) ≥ 40% decrease in IL-17 and IFNγ
production in primary T cells treated with our novel therapeutic.
The SBIR Phase II will perform IND-enabling safety and toxicology studies on the finalized topical formulation
of our compund, characterize the efficacy of combination therapies of our topical new therapeutic with currently
approved systemic agents for psoriasis, and initiate Phase 1b clinical testing in psoriasis patients.
Commercial Application: This SBIR will develop a first-in-class topical therapeutic for psoriasis for
addressing an unmet clinical need of 15 million patients, and a global market exceeding $12 billion annually.

Public health relevance
Public Health Relevance Inflammatory skin diseases afflict over 95 million people worldwide with over 7 million patients in the United States afflicted by psoriasis and 15 million worldwide. Despite the benefits provided with the current therapeutic options, there is an unmet clinical need for the development of safer and more long-term effective treatments for psoriasis. This SBIR Phase I application aims to develop our lead compound as a topical first-in-class therapeutic for psoriasis with a novel mechanism of action at the crosstalk between keratinocytes and immune cells.